Structural biology of host-pathogen interactions

This year we have made breakthroughs with studies of a variety of pathogen membrane embedded systems. In a study published in Nature Communications we demonstrated that Zorya phage defense systems share structural architecture with a family of ion-driven rotary motors that power flagella rotation, type 9 secretion, gliding and Ton-dependent nutrient uptake. Bacteria use these systems to provide themselves with immunity from phage attack. In separate studies on bacterial secretion systems, we revealed the structure of a plasmid conjugation regulatory protein, and separately characterized a type 7 secretion protein from Staphylococcus aureus that is used to kill competitor bacteria. Finally we were able to identify the structural basis of the transport of sugars by pathogenic fungi, thereby elucidating a mechanism of virulence.